The Influence of Ambient Air Pollution on Fertility Using a Vitrified Donor Oocyte Bank

PROJECT SUMMARY/ABSTRACT
Air pollution, particularly due to motor vehicles, is a ubiquitous exposure and a significant global health
threat, responsible for many adverse health outcomes. Emerging evidence also suggests that traffic-related
air pollution may be related to lower fecundity and fertility among couples attempting to conceive both with
and without medical assistance. However, the specific pollutants, exposure windows, and biological
mechanisms underlying these associations remain understudied. To address these important knowledge
gaps, this proposal will use a novel and emerging model of human fertility- vitrified donor oocyte assisted
reproductive technology (ART)- to evaluate how air pollution influences human reproduction using a large
cohort of oocyte donors and oocyte recipient couples attending a private fertility clinic in Atlanta, GA (2008-
2019). Residential exposure to traffic-related air pollution will be derived during multiple biologically relevant
windows of exposure in the female donor, female recipient, and male recipient partner using fine-scale
spatiotemporal models of nitrogen oxides, carbon monoxide, fine particular matter (PM), and elemental
carbon as well as sulfur dioxide, ozone, nitrogen dioxide, PM10 , and PM constituents. Vitrified donor oocyte
ART represents an ideal population to investigate the mechanisms underlying any associations between air
pollution and fertility as exposures to the oocyte and uterine environment are uncorrelated in time or space
and exposures to the oocyte and sperm are uncorrelated during the relevant exposure windows for
fertilization and embryo development. Furthermore, by studying patients undergoing ART, it is possible to
determine exact periods of air pollution exposure and directly observe early reproductive outcomes, such as
fertilization and early embryo development that would never be observed in couples conceiving without
assistance. This research will determine the independent effects of air pollution exposure during oogenesis
and spermatogenesis on fertilization and early embryo development, the independent effects of air pollution
on pregnancy outcomes as mediated through the oocyte and the endometrium, and the extent to which air
pollution affects fertility potential in young, healthy women. Findings from this proposal will have major

Public health relevance
PROJECT NARRATIVE This proposal will use a novel model of human fertility - vitrified donor oocyte assisted reproductive technology (ART) - to evaluate how air pollution influences human reproduction. Because vitrified oocytes are obtained from anonymous, young, healthy female donors months to years prior to the recipient couple's ART cycle, there is no correlation in exposure between the donor and the female recipient or the donor and the recipient's male partner. By leveraging this unique resource, our research will determine the independent effects of air pollution exposure during oogenesis and spermatogenesis on fertilization and early embryo development, the independent effects of air pollution on pregnancy outcomes as mediated through the oocyte and the endometrium, and the extent to which air pollution affects fertility potential in young, healthy women.